Neuropathology and inflammation in a nonhuman primate model of insulin resistance/metabolic syndrome

ABSTRACT
Epidemiological evidence indicates individuals with insulin resistance (IR), dyslipidemia characteristic of
metabolic syndrome (MetS) and type-2 diabetes mellitus (T2DM) are at heightened risk for developing
Alzheimer’s disease (AD) and Alzheimer’s disease related dementias (ADRD). To examine mechanisms
whereby MetS/IR/T2DM contribute to dementia risk and vice versa, we will employ a validated nonhuman
primate (NHP) model that employs a high sugar diet (HSD) that accelerates the progression MetS/IR/T2DM,
including rapid induction of IR, systemic inflammation and dyslipidemia. We propose a longitudinal investigation
of the relationships between metabolic dysfunction, diabetes, and dementia over the course of one year with
NHPs on HSD. A comprehensive, integrated analysis of central and peripheral endpoints is proposed,
specifically synaptic through biochemical, immunochemical, transcriptomic, and proteomic assessments of the
hippocampus, cortical regions comprising the default network mode (DMN), and mediobasal hypothalamus
(MBH) via advanced imaging (MRI and PET), and molecular/cellular studies linking neuropathology,
inflammation, mitochondrial and vascular dysfunction, and behavior in MetS/IR/T2DM with AD and ADRD. We
will employ this highly translatable NHP model to investigate the mechanisms underlying how MetS/IR/T2DM
drives AD/ADRD and vascular pathology, and why AD/ADRD/vascular dementia aggravate MetS/IR/T2DM in a
vicious cycle. We will assess vulnerable circuits and regions comprising memory (hippocampus), executive
function (DMN), MBH with parallel assessments of biobehavior, cerebrovascular function, blood-brain-barrier
(BBB), and peripheral pathways, especially targeting inflammation. Synaptic, and circuit level dysfunction will be
quantified in the context of biobehavioral and peripheral metabolic outcomes and advanced imaging, including
regional brain blood flow and glucose utilization. Aim 1 tests the hypothesis HSD in NHPs initiates AD/ADRD-
like pathology and vascular impairment within vulnerable regions underlying memory and executive function,
providing a mechanistic link between MetS/IR and pathological cascades in dementia. Aim 2 tests the hypothesis
that HSD produces functional deficits in the brain and periphery in macaques with MetS/IR/T2DM to increase
risk of AD, ADRD, and/or vascular pathology and behavioral deficits. Mechanistic investigation will be executed
by evaluating neuropathology, biobehavioral parameters, vascular/BBB perturbations, neuroinflammation,
impairments of insulin signaling and mitochondrial mass/function with changes in peripheral tissues (e.g., liver)
by coordinated immunochemical, proteomic, transcriptomic, and advanced imaging assessments in the same
animals. We propose rigorous assessments of the pathological effects of systemic MetS/IR/T2DM on the brain
and cerebrovasculature and molecular and cellular architecture in a validated NHP model to recapitulate these
prevalent, interrelated disorders. Results from NHPs are highly translational, and will contribute to innovative
approaches for managing and ameliorating deleterious effects of MetS/IR on AD/ADRD pathology and dementia.

Public health relevance
NARRATIVE Metabolic syndrome (MetS), insulin resistance (IR), and type-2 diabetes mellitus (T2DM) increase the risk of developing Alzheimer’s disease (AD), and Alzheimer’s disease related dementias (ADRD), and AD pathology worsens MetS/IR/T2DM pathobiology. To investigate the underlying mechanisms whereby MetS/IR contributes to AD/ADRD pathology and vascular dementia, we utilize a nonhuman primate (NHP) model of MetS/IR, dyslipidemia, T2DM, and systemic inflammation resulting from consumption of a high sugar diet (HSD) in order to address the scientific premise that MetS/IR/T2DM exacerbates molecular and cellular changes within the brain that promote pathogenesis of AD/ADRD which we will rigorously investigate in peripheral metabolic pathways and vulnerable hippocampal, cortical, and hypothalamic circuits, and cerebrovasculature via coordinated immunochemical, histopathologic, proteomic, and transcriptomic studies along with associated biobehavioral assessments and advanced imaging approaches. By addressing our hypothesis that the HSD initiates a vicious cycle between mechanisms underlying neurodegeneration and diabetes pathogenesis that result in the progression of both diseases, and whereby neuropathology is exacerbated by MetS/IR/T2DM, while impaired brain control of glucose and lipid homeostasis leads to a worsening progression towards T2DM, this proposal will provide novel information regarding mechanisms involved in these interactions and will lead to new and better targeted therapeutic interventions.